The role of antibodies in mother to child HIV transmission

ABSTRACT:
In order to harness the potential of the HIV-specific antibody response for prevention, it is important to define the
types of antibodies that block HIV infection or slow disease. Animal models are often used as a first step in
defining proof-of-principle concepts and many elegant studies in non-human primate models of HIV support the
potential of antibodies to provide protection from infection and disease. However, moving forward from these
studies, which are conducted under very controlled situations and with a single viral strain, to understanding
immune mechanisms of protection in the much more complex setting of natural HIV infection is challenging. It is
really only possible to study immune correlates in humans in situations where there are HIV-exposed individuals
who carry HIV-specific Abs where a subset remains uninfected while others succumb. This occurs in the setting
of mother-to-child transmission (MTCT) of HIV, particularly postpartum infection, where maternal antibodies are
passed to the infant and achieve their highest levels at birth. Thus, MTCT represents one of the few cases
where the characteristics of protective antibodies can be studied for HIV. Our team has several remarkable
cohort studies that uniquely position us to define immune correlates in MTCT. Our studies in the previous grant
cycle showed an association between non-neutralizing Abs capable of antibody-dependent cellular cytotoxicity
(ADCC) and infant outcomes. These studies represent one of the first to suggest a role for ADCC antibodies in
protection in exposed humans and support findings of the RV144 HIV vaccine trial. Here we propose to build on
these findings to more precisely define the target and function of the ADCC antibodies associated with better
infant outcomes using an array of innovative methods, including systems serology and a new phage display
method. We will further explore the nature of the ADCC activity using assays that measure ADCC in different
ways. We will isolate ADCC antibodies from highly infectious non-transmitting mothers to begin to define details
of the functional properties of protective antibodies and their origin. Because human studies are much more
complex and subject to confounding influences compared to experimental studies, determining if the same
correlates are identified in different cohorts is critical. Thus, this grant is design to take a broad approach to
defining correlates of protection in a first cohort study followed by testing of identified correlates in a second
cohort study. Overall, the proposed studies will leverage unique cohorts and exciting findings from the prior grant
cycle to provide critical insight into the characteristics of antibodies that contribute to protection from HIV-infection
in humans.

Public health relevance
PROJECT NARRATIVE One of the most promising strategies to blunt HIV infection and disease is using antibodies that target the virus. However, we don't really know what types of antibodies would be effective for this purpose in humans. We propose here to leverage the setting of mother-to-child transmission, where passive HIV antibodies are present in the infant when they are exposed to maternal virus, to identify the types of antibodies that may be beneficial against HIV.